Therapy for long-COVID in a preclinical model

ABSTRACT
New SARS-CoV-2 variants and novel coronaviruses will constantly arise and affect large proportions of
the worldwide population. Although the current wave of infections with Omicron subvariants is much less lethal
than that caused by previous SARS-CoV-2 variants (e.g., Wuhan-Hu1, Alpha, and Delta), about 10% of Omicron-
infected patients develop prolonged post-acute neurological sequelae involving cognitive impairments (“brain
fog”), difficulty concentrating, anxiety, and depression. Histological studies of brains from COVID-19 patients
have often observed immune cell infiltrates and increased frequencies of glial cells with inflammatory phenotypes
indicative of neuroinflammatory responses. Currently, there are no approved prophylactic or interventive
treatments for SARS-CoV-2-induced neuroinflammation.
There is a growing body of evidence that immune cells, microglia, and astrocytes express γ -aminobutyric
acid receptors (GABAA-Rs). The activation of these GABAA-Rs inhibits their pro-inflammatory activities and shifts
T cells, antigen-presenting cells, microglia, and astrocytes toward anti-inflammatory phenotypes. Taking
advantage of these properties, researchers have used homotaurine, a clinically applicable GABAA-R agonist that
can cross the blood-brain-barrier, to 1) reverse experimental autoimmune encephalomyelitis (EAE) a model of
multiple sclerosis (MS) and 2) reduce the levels inflammatory cytokines in the CNS, decrease neuronal loss, and
ameliorate behavioral deficits in a model of autism spectrum disorder. Furthermore, we have shown that GABAA-
R agonists reduce circulating proinflammatory cytokines/chemokines, viral replication in the lungs, the severity
of illness, and death in mice infected with two different coronaviruses: MHV-1 and SARS-CoV-2. Additionally, in
clinical trials, homotaurine treatment has had some promising beneficial effects in Alzheimer’s disease patients.
We contend that homotaurine is an excellent candidate for preventing and ameliorating SARS-CoV-2-
induced neuroinflammation. We will test this hypothesis in the hamster model of long COVID, arguably the best
rodent model available at this time. We anticipate that we will demonstrate the potential of an entirely new drug
class to help prevent and ameliorate SARS-CoV-2-induced neuroinflammation. Because homotaurine is safe for
human consumption, it could be rapidly tested in clinical trials. Since the mechanism evoked by GABAA-R
activation is unlike that of any other drugs being considered for treating long COVID, GABAA-R agonists are
likely to have enhanced therapeutic effects when combined with other treatments. Finally, the results may have
broader applications to treat other conditions involving CNS inflammation. Therefore, the results of our studies
may provide novel approaches to help improve the health of the global community.

Public health relevance
General Audience Summary This preclinical study will test the effectiveness of a new drug class to limit SARS-CoV-2 neuroinflammation that is associated with COVID-19 neurological complications. The results may have broader applications to treat other conditions involving CNS inflammation.